Mechanisms of platelet reprogramming during influenza infection

PROJECT SUMMARY
Influenza infection increases the incidence of acute MI (AMI) within the first 7 days after detection and
the therapeutic benefit of vaccination is comparable to current therapies for secondary prevention of AMI.
Platelets are the blood component central to thrombosis and uncontrolled platelet activation is a major contributor
to unstable coronary syndromes and AMI. Although thrombotic events have been associated with some viral
infections, the molecular mechanisms underlining platelet mediated thrombosis during progression of global viral
infection such as influenza have not been established. The major objective of this proposal is to examine the
role of a previously undescribed molecular mechanism in platelets that leads to sensing of influenza and
ultimately increased thrombosis. The mechanism of reference involves a cytoplasmic receptor known as the
retinoic acid-inducible gene-I (RIG-I) receptor and its downstream signaling cascade. Preliminary results show
that RIG-I and proteins related to RIG-I molecular signaling become specifically upregulated in platelets from
influenza infected patients. Since platelets are anucleated the upregulated expression of RIG-I suggests direct
involvement of their precursors the megakaryocytes (MKs) during infection. For that purpose, we will also study
the contribution of RIG-I in MKs to platelet reprogramming toward more efficient viral response that may lead to
thrombosis. Considering that the RIG-I-signaling axis is present in platelets and specifically upregulated, we
hypothesize that during infection, platelets sense influenza through the RIG-I signaling axis leading to their
activation and MKs reprogram platelets toward an increased antiviral and thrombotic response. Thus, we
propose two specific aims of research: Aim 1. To determine the expression and activity of the RIG-I axis in
platelets with respect to their antiviral and/or thrombotic responses; and Aim 2. To characterize how MKs sense
influenza and how this sensing subsequently reprograms the RIG-I/MAVS pathway, leading to enhanced
expression of antiviral and prothrombotic genes. Building upon novel observations obtained in preliminary
studies, our proposed research plan will determine the role of a previously unknown signaling pathway in
platelets, RIG-I/MAVS, in mediating influenza antiviral and thrombotic responses. The outcome of this proposal
will define the fundamental mechanisms of platelet viral cytosolic signaling, MK response to infection, how this
synergistic response contributes to immunity and thrombosis, and how targeting this pathway could ameliorate
thrombotic and infectious disease pathologies.

Public health relevance
PROJECT NARRATIVE Managing the impact of thrombosis is central to influenza-induced acute myocardial infarction. This research proposal will investigate the thrombotic and antiviral role of a previously undescribed mechanism in platelets that involves the retinoic acid-inducible gene-I (RIG-I) receptor signaling. Defining the signaling mechanisms that lead to influenza mediated activation of platelets and to their reprograming toward more robust antiviral and thrombotic responses, will enable us to design therapies managing thrombosis without negatively affecting antiviral response during infection.